Whole blood filter paper assay for Alzheimers Disease

SUMMARY
BioSpyder proposes to develop and validate a classifier test for Alzheimer’s Disease (AD) that may also
classify other dementias. Biospyder will market this as an RUO, then pursue development as a definitive in
vitro diagnostic (IVD) test, addressing a major unmet need. The program is based on a very successful Phase
I. It was found that a classifier using whole blood from a finger-stick spotted on filter paper and assayed using
the whole transcriptome TempO-Seq® gene expression assay (the WBFP TempO-Seq assay) produced
signatures for both AD and Parkinsons’s Disease that permitted a classifier to be built that identified each
initially with 87% accuracy. After retraining with additional AD samples, the WBFP TempO-Seq AD classifier
identified 100% of an independent testing cohort of AD samples correctly, and identified immune cell functional
pathways underlying the signature. AD is the most common form of dementia, with the risk of developing AD 1
in 5 for women, 1 in 10 for men. Mild cognitive impairment (MCI) can be noticed years before those patients
can be diagnosed with AD or another dementia, years of uncertainty, no treatment, lost time to prepare for a
future with AD. That diagnosis requires cognitive testing administered by a neurologist, with in some cases
confirmation by a -amyloid PET scan. Biomarker immunoassays recently cleared under the Breakthrough
Device designation are not definitive and require cognitive testing or a -amyloid PET scan for diagnosis, and
require drawing blood or collecting cerebral spinal fluid. Thus, the still unmet need for a definitive IVD. In this
Phase II we will validate the performance of the WBFP TempO-Seq assay to classify AD patients, ability to
classify patients with other dementias, establish how early after presenting with MCI patients can be identified
with AD, correlate the WBFP TempO-Seq assay classification to -amyloid PET scans and immunoassay,
implement/validate performance of a focused WBFP TempO-Seq AD or pan-dementia test, and prepare the
materials for, and meet with, the FDA in a pre-IDE meeting to discuss the studies required for an application for
clearance as an IVD. The WBFP TempO-Seq whole transcriptome, focused, AD and focused pan-dementia
tests will be marketed for RUO use to identify novel therapeutic targets, characterize the progression from MCI
to AD, facilitate drug discovery efforts and selection/classification of patients, and potentially for development
as companion diagnostic tests. If the WBFP TempO-Seq AD or pan-dementia tests are FDA cleared, they will
be transformative, not just by providing a definitive diagnosis of AD or other dementias, but potentially by
providing that diagnosis before a diagnosis by cognitive testing can be made, and as importantly, by enabling
self-collection of samples to address health disparities in families and populations that do not have affordable
or easy access to a neurologist. If providing early, definitive diagnosis, any clinic or physician (or family
members) can evaluate persons for AD and potentially other dementias, broadening the network able to
provide diagnosis and focusing the role of the neurologist onto therapy and care.

Public health relevance
NARRATIVE Phase I data demonstrates the feasibility of producing a gene expression-based assay for the highly accurate classification of patients with Alzheimer’s Disease and other dementias using a sample of blood spotted on filter paper which is easy to collect in the doctor’s office, clinic, or even by self-collection. The validation of this assay in Phase II with multiple cohorts of samples, correlation to FDA-approved tests, and use to elucidate potential novel therapeutic targets and the launch of RUO whole transcriptome, Alzheimer’s, and pan- dementias tests will be transformative for the field of neurodegenerative diseases at the levels of basic research, translational research, and drug discovery and development, as will the subsequent development into a definitive Alzheimer’s or pan-dementia diagnostic assay. By enabling self-collection, this test may also reduce health disparities and transform the diagnosis of Alzheimer’s Disease and other dementias to permit neurologists to focus on confirmation and treatment rather than diagnosis.